Transcriptional diversity of human mediodorsal thalamus and its role in psychiatric disease

Schizophrenia (SZ) and bipolar disorder (BP) are devastating, highly heritable brain disorders that affect millions
of people worldwide. Current treatment options often fail to adequately control symptoms, and relapses are
common. Numerous genetic variants associated with risk have been identified, but progress is hindered by
limited understanding of the mechanisms by which genetic variants act within the brain to confer disease risk.
One consistent finding in patients with SZ and BP is reduced connectivity between the thalamus, particularly the
mediodorsal thalamus, and prefrontal cortex. While the molecular basis of this reduced connectivity remains
unclear, recent findings link brain connectivity to regional variation in gene expression, itself a function of cell
type and inherited genetic variation. In this K22 application, I propose an integrated training and research
program aimed at developing my knowledge and skills in human genetics and bioinformatics, while building upon
my strong background in molecular neuroscience and single-cell genomics. I will investigate the overarching
hypothesis that known differences in thalamocortical connectivity in SZ and BP are accompanied by
transcriptional differences in the mediodorsal thalamus. These transcriptional differences can now be precisely
defined by new technologies that illuminate genomics and transcriptomics at single-cell resolution in post-mortem
human brain. I will also investigate how inherited genetic variants affect cell type-specific gene expression in
thalamus. Such variants will then be compared to common variants known to confer risk for BP or SZ, potentially
elucidating one mechanism whereby genetic variants confer risk for major mental illness. In Aim 1 I will use
single-nucleus RNA-sequencing to define transcriptional signatures of diverse cell types in human mediodorsal
thalamus and then use these signatures to explore differences in cell type-specific gene expression in post-
mortem brain obtained from people diagnosed with SZ or BP and non-psychiatric controls. I will also explore the
effects of known risk alleles on cell type-specific gene expression in mediodorsal thalamus and compare the
thalamic transcriptomes with those of interconnected cortical regions in the same patients. Since gene
transcription is often driven by dynamic changes in chromatin, in Aim 2 I will use single-cell ATAC-seq to identify
regions of accessible chromatin in post-mortem human mediodorsal thalamus. By integrating these data with
common genetic variants, I will identify candidate cis-regulatory elements that influence chromatin accessibility
in thalamus. These variants will be good candidates for future work aimed at linking genetic risk for SZ and BP
to cell type-specific gene expression changes within the mediodorsal thalamus and associated brain regions. If
successful, this novel integration of genetic, transcriptomic, and chromatin-accessibility data in human thalamus
will deliver new insights into the mechanisms by which common disease-associated genetic variants affect
cellular physiology in the brain. This project will provide me with a foundation of training and research experience
that is essential for my future plans to study the thalamus and its role in the pathogenesis of SZ and BP.

Public health relevance
Schizophrenia and bipolar disorder are severe psychiatric conditions affecting millions of people worldwide. Improved understanding of the role of the thalamus in these disorders will shed light upon their neurobiological correlates and may help inform novel methods of diagnosis and treatment.